AphasiaBank: A Shared Database for the Study of Aphasic Communication

This project seeks to enhance the value of the AphasiaBank database and tools
for the study of spoken language and communication as used by people with
aphasia. We will do this through the introduction of innovative methods for
automatic speech recognition, discourse analysis, gesture analysis, corpus
analysis, and a new system called collaborative commentary. We will apply these
new methods to the analysis of the current database, as well as many new
corpora. We will configure these new methods for widespread use by both
researchers and clinicians.

Public health relevance
This project seeks to enhance the value of the AphasiaBank database and tools for the study of spoken language and communication as used by people with aphasia. We will do this through the introduction of innovative methods for automatic speech recognition, discourse analysis, gesture analysis, corpus analysis, and a new system called collaborative commentary. We will apply these new methods to the analysis of the current database, as well as many new corpora. We will configure these new methods for widespread use by both researchers and clinicians.